Unique ubiquitin processes in misfolded protein diseases of the nervous system

Age-related diseases of the nervous system are diverse and will continue to grow in importance as the population ages. So far, the most impactful among them have eluded successful clinical intervention; therefore, their investigation constitutes a clear need in the field of neuroscience. Among these diseases are Alzheimer's, Parkinson's and the polyglutamine family of disorders, caused by the presence, accumulation and aggregation of misfolded proteins. Ground-breaking work has dissected how cells coordinate responses to delay or suppress misfolded protein toxicity, yet neurons ultimately succumb to these proteins and diseases progress. Among processes involved in maintaining neuronal homeostasis in the face of misfolded proteins are refolding and degradation pathways. Key to these processes is the small modifier protein, ubiquitin. Here, we seek to investigate an aspect of ubiquitin that has eluded exploration in neurodegeneration: unanchored, or free, ubiquitin chains and their impact on misfolded protein toxicity. Ubiquitin is best known for targeting substrates for proteasomal degradation by being chemically tethered onto them. Ubiquitin exists in numerous types of configurations, including chains that can adopt a wide array of topological complexities and length, and that coordinate downstream substrate recognition and processing. Among the types of poly-ubiquitin chains are unanchored species that are not attached onto other proteins. We recently published evidence on the presence, function, utilization and processing of these chains in vivo. Among the most intriguing findings was the observation that free ubiquitin chains can be conjugated onto substrates en bloc, without the need to be first dismantled into monomers. This novel finding led us to wonder whether it may be beneficial for cells under stress to use ready-made chains to maintain homeostasis. In pilot examinations we found that free ubiquitin chains suppress toxicity from disease-causing proteins. Our pilot data lead us to hypothesize that unanchored poly-ubiquitin is beneficial to the cellular response to misfolded disease proteins. We propose to test this hypothesis through three aims that utilize a combination of physiological and biochemical assays.

Public health relevance
Age-dependent neurodegeneration is a major health issue and options to fight it remain elusive. We seek to investigate previously uncharacterized ubiquitin mechanisms to understand the cellular response to proteins that cause degenerative diseases. Our results are expected to shed light on novel therapeutic entry points for age-related disorders caused by neurotoxic proteins.